Neurophysiological Correlates of Visual Motion Processing in Cerebral Visual Impairment

Summary
Cerebral (cortical) visual impairment (CVI) is the leading cause of congenital vision impairment in the United
States. Yet, there remains an alarming gap in our understanding as to how observed visual perceptual deficits
in these individuals relate to perinatal damage and early maldevelopment of central visual pathways and
structures. Children and adolescents with CVI show striking impairments in complex motion processing (a
dorsal stream function), particularly in the setting of complex dynamic environmental scenes. While impaired
motion perception is an important marker of developmental vulnerability (referred to as the dorsal stream
dysfunction hypothesis), standard ophthalmic clinical assessments fail to capture and fully characterize these
visual deficits. Thus, in the absence of any apparent ocular abnormality, clinicians may dismiss reported
perceptual difficulties, and many individuals with CVI will remain undiagnosed and never receive the timely
education and rehabilitative support they need. The objective of the proposed research is to investigate the
underlying neurophysiology associated with motion processing deficits in CVI. We will carry out psychophysical
behavioral testing combined with multimodal neuroimaging (to characterize structural and functional
connectivity along with brain network activation) in children and adolescents with CVI associated with
periventricular leukomalacia (PVL). Indices of behavioral performance and neuroimaging outcomes will be
compared to neurotypical controls. Our overarching hypothesis is that motion processing deficits will be
associated with the maldevelopment of key visual processing pathways. However, altered patterns of
functional connectivity and activation of brain networks implicated in complex motion perception may serve as
indicators of compensatory neuroplasticity. In our first aim, we will assess motion processing abilities using
random dot kinematograms, virtual reality simulations, and visual search tasks. In our second aim, we will
characterize the integrity and topology of structural and functional connectivity networks (using high angular
resolution diffusion imaging and resting state fMRI respectively) implicated with visual motion and attention
processing. The third aim will investigate brain network activation (using functional MRI) in response to our
behavioral task assessments. Executed by a multidisciplinary research team with strong community
involvement, this combined behavioral assessment and multimodal imaging approach represents a key
distinguishing innovation of the proposal. This study will provide convergent and high-level insights into the
neurophysiological basis of visual motion perceptual deficits in CVI. The proposed program of research is
highly significant given that uncovering brain-behavioral associations in the case of CVI represents a crucial
step in establishing a neurorehabilitative framework specifically designed for the care of these children; a
population that has been greatly underserved despite its important

Public health relevance
Project Narrative The objective of this study is to better understand the underlying neurophysiology associated with motion processing deficits in cerebral (cortical) visual impairment (CVI). CVI is the leading cause of congenital visual impairment in the developed world yet, little is known as to how visual perceptual deficits in these individuals relate to early maldevelopment of central visual pathways and structures. We will carry out psychophysical behavioral testing combined with multimodal neuroimaging to characterize brain-behavioral relationships associated with motion processing deficits; which is an important marker of developmental vulnerability.